Bayesian Differential Causal Network and Clustering Methods for Single-Cell Data

Project Description
DMS/NIGMS 2: Bayesian Differential Causal Network and Clustering Methods for Single-Cell Data
A Signiﬁcance
A.1 Importance of the Problem to Be Addressed
Single-cell RNA-sequencing (scRNA-seq) technologies have facilitated new biological discoveries that were
impossible with bulk RNA-seq, such as discovering at the single-cell level new gene regulatory activities and
cell types. However, in order to translate the fundamental biological knowledge advanced by the scRNA-
seq to improved disease diagnosis, treatment, and prevention, new methods are required to comparatively
study the molecular differences between normal and pathological cells/tissues, and between control and
case/treatment groups. Although identiﬁcation of differentially expressed genes across two sample groups
has been extensively studied, to date, the vast majority of the existing methods for identifying gene regu-
latory networks (GRNs) and cell types have, so far, focused on scRNA-seq data generated under a single
experimental condition. In principle, these methods can be applied to one experimental condition at a time,
based on which post hoc comparisons can be made in order to ﬁnd the differences caused by experimental
interventions. However, compared to joint modeling approaches, this two-step procedure is deemed less
efﬁcient and more susceptible to false discoveries due to lack of proper uncertainty propagation from the
ﬁrst step to the second. Moreover, most scRNA-seq network models are correlative in nature and do not
infer causal gene regulatory relationships. There is, therefore, a critical need to develop new models for
identifying the effects of experimental interventions on causal gene regulation and cell composition by jointly
modeling scRNA-seq data across experimental groups. In the absence of such tools, mechanistically un-
derstanding gene regulation and cell differentiation, and fully realizing the translational values of scRNA-seq
studies will likely remain difﬁcult.
A.2 Rigor of Prior Research
Aim 1. Many existing scRNA-seq network approaches adapt standard association measures to zero-
inﬂated scRNA-seq data, e.g. Pearson correlation [1] and mutual information [2]. A common limitation
of these methods is that they only quantify marginal dependencies, which is susceptible to spurious indirect
associations [3]. Graphical models which deal with conditional associations are powerful alternatives to
the marginal association measures. Numerous methods have been proposed for general purposes [4, 5]
including the development on non-Gaussian data [6–9]. Speciﬁcally for scRNA-seq data, two undirected
graphical models including Co-I Cai's work [10, 11] were recently proposed based on neighborhood selec-
tion which, however, do not infer causal gene regulation. To identify causal relationships, several alternative
methods [12, 13] were developed. However, these methods either ignore the count nature of scRNA-seq
data, require a known pseudotime (which is rarely known in real scRNA-seq data), or do not theoretically in-
vestigate causal identiﬁability for cross-sectional observations. For differential networks, many approaches
[14–18] including the PI's prior work [19] have been developed for bulk RNA-seq data which showed great
advantages of joint analyses over independent analyses. However, there exist much fewer differential net-
work methods for scRNA-seq data, e.g., PT [20] and scdNet [21] . The common limitation of PT and
scdNet is that they only consider marginal dependence (hence susceptible to false discoveries) and do not
discover causality. Results from our preliminary results (§C.1) demonstrate that the proposed Bayesian
network model is capable of identifying causal gene regulatory relationships in cross-sectional scRNA-seq
data and often outperforms the state-of-the-art alternative methods.
Aim 2. Very few methods are available to construct cell-speciﬁc networks because it is difﬁcult to estimate
networks with, in essence, sample size one. Recently, a hypothesis testing approach [22] was developed
to estimate cell-speciﬁc networks. The method makes approximate network inference of each cell based
on its neighbors. However, it only considers symmetric (undirected) marginal dependence, and therefore
cannot infer causal regulatory relationships and is susceptible to spurious associations. The PI's prior work
[23] addressed the "sample-size-one" problem in bulk RNA-seq data assuming the causal networks are
smooth functions of additional covariates. However, the method is not applicable without covariates and
does not allow feedback loops, a common motif in GRN. Existing work [24, 25] including the PI's [19] has
1